Clinical Research Support Services for NIEHS Contract Task Order 11 Role of oxidant susceptibility genes in severity on neonatal diseases associated with hyperoxic injury (Argentina Study)

The purpose of this severable task order is to provide support of research oversight and coordination of recruiting very low birthweight infants and their parents for a study being conducted in BuenosAires, Argentina titled Role of oxidant susceptibility genes in severity of neonatal diseases associated with hyperoxic injury.